Circadian and sleep mechanisms among racial groups for nicotine dependence, craving, and withdrawal

PROJECT SUMMARY
The number one preventable cause of death in the world is tobacco use. Cigarette smoking in particular, costs
an estimated $300 billion due to expenses related to medical care and lost productivity. Despite similar smoking
prevalence rates, Blacks suffer disproportionately from smoking-related harms compared to Whites. Sleep
disparities such as shortened sleep duration, shorter circadian periodicity, earlier chronotype, and increased
variability of sleep timing have been reported more frequently in Blacks compared to Whites. Given that poor
sleep quality predicts relapse from smoking cessation programs, particularly among socioeconomically
disadvantaged adults, sleep deficiencies and irregular timing of sleep may impact smoking craving and
withdrawal symptoms over the course of the 24-hour day. Surprisingly, few studies have examined these
temporal patterns of smoking and craving, and none with regard to sleep disruption, chronotype or racial
disparities. A better understanding of these factors may explain heterogeneity within the smoking population,
especially in minorities. Thus, the purpose of this proposal is to test the central hypothesis that the impact of
chronotype and impaired sleep on cigarette usage as well as smoking dependence, urge/craving, and withdrawal
depends on race. Three specific aims will determine: contributions of sleep timing and sleep quality and quantity
to racial disparities in smoking status (Aim 1), objective sleep characteristics and smoking behavior among
blacks and whites who smoke cigarettes (Aim 2), and whether sleep restriction modifies craving and withdrawal
in racially diverse smokers (Aim 3). Specifically, we will utilize self-report questionnaires, objective measures of
sleep quality and timing (actigraphy) and circadian phase (dim light melatonin onset), as well as ecological
momentary assessment of cigarette use, smoking urges, cravings, and withdrawal symptoms to identify circadian
and sleep characteristics that are most strongly associated with smoking status, heaviness of smoking and
dependence among blacks and whites. Finally, we will test whether acute sleep restriction (4 hours of time-in-
bed) versus sleep extension (10 hours of time-in-bed) modifies craving and withdrawal symptoms following
cessation in black and white smokers. If successful, the results of this study will result in identification of circadian
dysfunction and insufficient sleep as mechanisms that underlie the association between sleep and cigarette
smoking behaviors and dependence in diverse populations. Moreover, these findings are likely to inform
clinicians of the importance of sleep and sleep timing on cigarette smoking behaviors and dependence that will
help in the development of novel interventions to reduce morbidity and mortality caused by tobacco use.

Public health relevance
PROJECT NARRATIVE Cigarette smoking and nicotine dependence have been associated with delayed sleep timing, poor sleep quality and quantity, as well as sleep disordered breathing and insomnia. Our goal is to identify the contributing factors to smoking status, determine circadian characteristics of smoking behavior, and to determine the effects of acute sleep restriction on smoking withdrawal in racially diverse populations. Overall, this study will help to identify targets for smoking cessation strategies as well as lead to novel therapeutic interventions for sleep disruption and smoking abstinence, particularly among ethnic minorities.